Modeling of cell-specific LRP1 signaling in acute myocardial infarction

SUMMARY Modeling cell-specific LRP1 signaling in acute myocardial infarction
Improving the treatment of acute myocardial infarction (AMI) to prevent heart failure (HF) and death remains an
urgent unmet medical need. The AHA estimates that every 42 seconds an American will have an AMI, and
despite the improvement in treatment and prognosis, a significant number of patients develop continue to
develop HF or die. The AHA estimates that 17 years of life are lost due to AMI. With a rising prevalence and high
incidence (>900,000 new cases per year in USA alone), AMI and HF are important public enemies.
Low-density lipoprotein receptor related protein-1 (LRP1) is a membrane receptor known as scavenger for the
serine protease inhibitor (SERPIN)-enzyme complex (SEC), linked to anti-inflammatory and cytoprotective
signaling. We and others have described the protective activities of LRP1 in ischemia-reperfusion injury during
AMI. We showed that non-selective LRP1 agonists, and more recently, that a targeted small peptide selectively
engaging LRP1, SP16, reduced infarct size in experimental animal models.
LRP1's role in ischemia-reperfusion injury and infarct healing is, however, complex as LRP1 is involved not only
in the cell survival pathway but also in the wound healing and repair process regulating fibroblast proliferation.
We hypothesize that after acute myocardial infarction, LRP1 transduces an early beneficial
cardiomyocyte-specific signaling network but a late detrimental fibroblast-specific signaling network
that can be leveraged for therapeutic purposes. We will test this overall hypothesis by combining cell-specific
network modeling with cellular and mouse experiments in two specific aims.
In Aim #1, we expand and experimentally validate a signaling network that predicts how early cardiomyocyte
LRP1 signaling enhances cell survival after ischemia-reperfusion in cells and mice. Network modeling combining
LRP1 mechanisms, survival signaling, and downstream ischemia-reperfusion modules will predict network
mechanisms mediating LRP1-dependent survival. Experiments will leverage pharmacologic and our new
cardiomyocyte-specific LRP1 gene KO mouse model with subject to AMI. In Aim #2, we will expand and
experimentally validate a signaling network that predicts how late fibroblast LRP1 signaling stimulates fibrotic
phenotypes in cells and mice. We will integrate single-cell RNA-sequencing with fibroblast network modeling that
identifies LRP1-dependent pathways in AMI. These will be validated using our new fibroblast-specific LRP1 gene
KO mouse model subject to AMI. Together, computational-experimental studies of cell-specific LRP1 signaling
networks will reveal how early exogenous LRP1 agonists promote cardiomyocyte survival while late endogenous
LRP1 agonists promote fibrosis. These insights will provide distinct therapeutic targeting opportunities for AMI
and HF.

Public health relevance
NARRATIVE Modeling of cell-specific LRP1 signaling in acute myocardial infarction The American Heart Association estimates that every 42 seconds an American will have an acute myocardial infarction (AMI), and despite the improvement in treatment and prognosis, a significant number of patients continue to die and AMI survivors remain at high risk of developing heart failure (HF). Low-density lipoprotein receptor related protein-1 (LRP1) is a membrane receptor known as a scavenger for the serine protease inhibitors (SERPINs) that also possesses anti-inflammatory and pro-survival signals in cultures cardiomyocytes and proliferative signals in fibroblasts. We propose that using modeling to define the differential signaling pathways of LRP1 in cardiomyocytes and cardiac fibroblasts may open the way to novel therapeutic strategies targeting LRP1 in AMI, heart failure, and other related diseases.